The micro made macro: Microsurgery at human scales

PROJECT SUMMARY
Microsurgery is at the forefront of modern surgical practice. The quest for ultra-precise
resection of invading tumors, durable anastomosis of severed neurovascular structures, and
overall minimization of invasiveness has driven the scale of surgical maneuvers below a
millimeter and ﬁrmly into the microsurgical domain. Applications of microsurgery abound,
commensurate with the potential patient beneﬁts, including tissue sparing, better margins,
function restoration, and reduced pain. Uniting its diverse procedures is the deﬁning
characteristic of microsurgery and the source of its challenges: the sub-millimeter scale of
surgical maneuvers and target tissues. The human motor and perception systems are
ill-equipped to operate in this regime, and microsurgeons thus reach intrinsic limits of human
performance and encounter shortcomings of surgical aids at microsurgical scales. Fortunately,
advances in robotics, virtual reality (VR), and artiﬁcial intelligence (AI) promise to solve these
fundamental challenges from manipulation, visualization, and workﬂow standpoints,
respectively. These incredible advances and, in some cases, commercial products fail
microsurgeons from the perception standpoint, however. The project therefore proposes to
develop an adaptive perception system based on optical coherence tomography (OCT) to
satisfy this unmet need in microsurgery. Speciﬁcally, adaptive perception leverages an
AI-derived understanding of the surgical scene and its dynamics to build a high-ﬁdelity 3D
reconstruction from intelligently distributed image acquisition effort. Critically, OCT is the only
live volumetric medical imaging modality routinely acquired during surgery and thus presents a
unique opportunity in microsurgery for 3D surgical feedback. Leveraging adaptive perception to
guide surgery for natural and artiﬁcial agents, this project will create an OCT-integrated robotic
microsurgery system capable of autonomous and VR tele-microsurgery modes. Its core
capabilities include an OCT-based adaptive perception system that predicts and responds to the
microsurgeon’s or AI’s visualization needs, immersion of the microsurgeon in a life-size VR
environment constructed from live volumetric OCT upsized 100-1000x to human scale, and
AI-guided automated microsurgical suturing without ﬁducial markers. This project further
proposes to compare this system to conventional techniques in simulated and ex vivo
microsurgical procedures. This platform promises to empower microsurgeons to complete their
tasks faster, commit fewer technical errors, require less training to reach proﬁciency, and enjoy
improved ergonomics. These beneﬁts would translate into the downstream patient beneﬁts of
improved outcomes, reduced anesthesia time, faster recoveries, and easier access to care for
hundreds of thousands of microsurgery patients each year. These innovations and applications
promise to transform microsurgery in ways that could not be envisioned even a few years ago.

Public health relevance
PROJECT NARRATIVE Microsurgery is among the most demanding techniques for surgeons, who reach fundamental limits of human performance at microsurgical scales. This application proposes an innovative surgical platform that combines robotics, virtual reality, and artiﬁcial intelligence with adaptive intrasurgical perception to transcend these limits. These advances will enable more effective, eﬃcient, and ergonomic surgical care to the beneﬁt of both patients and microsurgeons.